Plan to Enhance Diversity

PROJECT SUMMARY/ABSTRACT (PLAN TO ENHANCE DIVERSITY)
The University of Michigan (U-M) Rogel Cancer Center (Rogel) is committed to creating a supportive
environment for all and sustaining diversity of Rogel leadership, faculty, scientific workforce and trainees.
Diversity, Equity, Inclusion and Justice (DEIJ) is one of six pillars for Rogel’s new five-year Strategic Plan
(2022-2027), and central to a comprehensive Plan to Enhance Diversity (PED). The Rogel DEIJ strategic plan
is informed by and integrated with U-M institutional efforts, and spans Rogel’s corresponding strategic pillars for
research, training, community outreach, patient care and infrastructure. The Rogel DEIJ Advisory Council
(DEIJ-AC) consists of faculty, staff, trainees, patients and community members, and meets quarterly to ensure
oversight of five key areas: Workforce, Leadership, Training and Education, Community Outreach, and Clinical
Research and Care. The Rogel PED ensures inclusive recruitment strategies and leverages institutional
commitment to recruit and retain diverse faculty, and utilizes established infrastructure to cultivate and promote
a supportive climate for both faculty and staff. New career development and research opportunities for
underrepresented populations in the scientific workforce (URSW) are proceeding to foster diversity in present
and future Rogel leadership, including an Emerging Leaders Council with seats on the Rogel Executive
Committee, and internal funding structures to support cancer health equity research. The diversity of the
Rogel pipeline is bolstered across the continuum by initiatives supporting regular engagement of trainees,
undergraduates and K-12 students with leaders from Rogel and U-M more broadly. Substantial
progress in systemic diversity enhancement throughout the Rogel has already been achieved, and dynamic
measures are already underway to further improve and ensconce the tenets of the Rogel DEIJ strategic pillar.